Response Properties of Meningeal Afferents in Health and Migraine

The cranial meninges, which provide a physical and immunological barrier to protect the brain, are
innervated by a network of trigeminal primary afferent sensory neurons. A large body of indirect evidence
points to meningeal afferents' involvement in migraine headache genesis. However, we do not yet have
a clear understanding of the normal sensory function of meningeal afferents and how they become
engaged in migraine. Our current knowledge about the response properties of meningeal afferents has
been almost exclusively derived from single-unit recordings of dural afferents from their TG somata in
anesthetized rats with surgically exposed and depressurized meninges. Yet, these recordings have only
provided a coarse description of the stimuli sensed by the diversity of meningeal afferents. To better
understand the function of meningeal afferents, we recently developed a two-photon, GCaMP-based
Ca2+ imaging approach to monitor their responses to a large set of complex physiological and pathological
stimuli in the intact intracranial space of awake mice. By imaging the activity of meningeal afferent fibers
in naïve mice via a closed cranial window, we made the surprising observations that despite their
presumed nociceptive function, a large subset of afferents becomes activated during brief locomotion
bouts and displays distinct dynamics to various levels of meningeal deformations that occur in response
to locomotion. We now propose to leverage our newly developed imaging approach to advance our
understanding of the sensory function of meningeal afferents and how their response properties are
modulated under conditions that have been implicated in migraine headaches in humans Studies in Aim
1 will investigate the novel idea that the meningeal sensory system is tuned to sense a wide range of
interoceptive mechanical stimuli, including physiological meningeal vasodilation and intracranial pressure
elevations. In Aim 2, we will test the prediction that migraine triggers amplify these normal sensory
responses. Aim 3 is to explore the relative contribution of the mechanosensitive Piezo2 channel in
mediating the afferents' responses to normal intracranial interoceptive signals and their amplification
following the administration of migraine triggers. Our proposed studies and innovative approach to image
the activity of meningeal afferents could provide a dramatically better understanding of the role of the
meningeal sensory system in homeostasis and under pathophysiological conditions that lead to migraine.
Advances made could accelerate preclinical translational headache research.

Public health relevance
The trigeminal sensory innervation of the cranial meninges has been implicated in headaches and migraine. Yet, we do not clearly understand its sensory function and how it becomes activated in migraine. Our proposal will bridge this gap in knowledge by investigating the normal response of meningeal afferent neurons and the effects of agents implicated in migraine triggering in awake-behaving mice. Advances made could accelerate preclinical translational headache research.